Tulane Clinical Center for Chronic Renal Insufficiency Cohort Study

PROJECT SUMMARY
Chronic kidney disease (CKD) affects over 37 million Americans and increases the risk of end stage kidney
disease, cardiovascular disease, and premature mortality. Since its inception in 2001, the Chronic Renal
Insufficiency Cohort (CRIC) Study has recruited and followed a racially and ethnically diverse cohort of 5,625
participants with reduced kidney function at 7 Clinical Centers across the US. The original aim of CRIC was to
identify novel risk factors for CKD progression and cardiovascular disease among individuals with CKD. As the
landmark prospective cohort study of CKD, the CRIC Study has accomplished extensive biological,
physiological, and social phenotyping, longitudinal follow-up, and ascertainment of clinical and patient-centered
outcomes across multiple domains. Findings from the CRIC Study have defined trajectories of CKD
progression, catalogued the development and evolution of comorbidities in CKD, and identified a diverse array
of factors and pathways that explain the progression and complications of CKD in adults. Through its highly
productive Ancillary Studies and Opportunity Pool Programs, both the scientific scope of the CRIC Study and
the community of kidney disease researchers have been markedly expanded. During the most recent funding
cycle (Phase 4: 2018-2023), three innovative sub-protocol studies were implemented to enrich CRIC data with
highly granular home-based assessments of kidney function and cardiovascular measures. During the fifth and
final phase of the CRIC Study, the major focus will be to 1) ascertain the clinical outcomes for all participants
including those enrolled in the Phase 4 sub-protocols, 2) perform analyses linking the sub-protocol
measurements to clinical outcomes, 3) integrate data from multiple domains to identify sub-phenotypes
underlying the heterogeneity in CKD progression outcomes, 4) conduct final study visits for the full CRIC
cohort eligible for Phase 5, 5) create mechanisms for future data collection via linkages with external sources
of health data, and 6) generate tools and resources to facilitate the ongoing use of CRIC data and
biospecimens by a broad group of investigators after the study’s official end. To achieve the above goals, the
Tulane CRIC Clinical Center will reconsent and reenroll a high proportion of the 278 active study participants
into CRIC Phase 5; complete study visits and data collection with a stringent quality control process; actively
develop and participate in Ancillary Studies; maximize scientific productivity by leading and participating in
scientific presentations and publications; network with non-CRIC Study researchers to integrate CRIC data
with non-CRIC data to increase scientific output; provide training opportunities for the next generation of
researchers; and facilitate linkages between participant-level CRIC data and key external data sources to
enable the acquisition of additional data for future investigations. These proposed activities will generate new
scientific output and successfully transition the CRIC Study from its active prospective cohort phase to a long-
lasting resource for supporting ongoing and future mechanistic, epidemiologic, and translational investigations.

Public health relevance
PROJECT NARRATIVE The Chronic Renal Insufficiency Cohort (CRIC) Study is an NIDDK-sponsored multicenter prospective cohort study investigating novel risk factors for the progression of chronic kidney disease and cardiovascular disease among patients with chronic kidney disease. The CRIC Study may provide insights into the underlying etiology of chronic kidney disease and information for developing interventional studies aimed at reducing the total morbidity and mortality burdens among patients with chronic kidney disease.